A patch circuit dissection of opioid addiction

PROJECT SUMMARY/ABSTRACT
The opioid crisis remains a major health concern with millions of Americans addicted to opioid drugs and
thousands of opioid related deaths per year. The sad reality is that while medication assisted therapies are highly
effective, relapse rates remain high. More understanding is needed into the neurobiology and circuits of opioid
addiction to identify new therapies. Opioids exert their rewarding and addictive effects through action at the mu
opioid receptor (MOR). The MOR is expressed widely throughout the nervous system including regions
associated with drug reward such as the nucleus accumbens. It is present in a peculiar neuroanatomic
organization referred to as “patch” or “striosome,” with dense regional expression situated in a network of islands
throughout dorsal striatum and nucleus accumbens. The region outside of these islands is referred to as matrix.
The functional relevance of this level of neuroanatomic organization is mysterious and its consequence for opioid
use disorders is almost completely unknown. While the direct and indirect pathway of striatal organization has
revealed critical insights into motivated behavior and pathologic changes associated with substance use
disorders, it remains incomplete especially in regions of the ventral striatum such as the nucleus accumbens. The
neuroanatomy of “patch” vs “matrix,” and the cell types contained within each compartment, opens the
possibility for a revived lens through which to look at the functional organization of the nucleus accumbens in
motivated behavior and addiction. Recently, the power of mouse genetics revealed two separate populations of
direct pathway medium spiny neurons housed within MOR positive patch networks. Further work has shown
that while one population encodes positive valence and positive reinforcement, the other encodes negative
valence and negative reinforcement, challenging the traditional dogma of the direct pathway. This proposal
resubmission begins to define a role for these cell populations in preclinical models of opioid abuse, investigating
the properties of patches in the valence of opioids and withdrawal, opioid consumption, maintenance, extinction
and reinstatement. Input and output circuitry will be defined in each patch cell type within the nucleus
accumbens. The work will combine opioid self-administration, behavioral economic analysis, viral
neuroanatomic techniques, optogenetic and chemogenetic manipulations and cell type neuroimaging with fiber
photometry. This work will be among the first to study MOR (+) patch circuits in the context of opioid use
disorder. Through this new lens of functional organization, insights can be revealed that could lead to new
therapies in treating the devastating health and societal impact of opioid use disorders.

Public health relevance
PROJECT NARRATIVE Opioid use disorders present a devastating and major public health concern and are marked by behaviors such as a compulsive desire to use opioids despite negative consequences, severe withdrawal symptoms upon drug abstinence and incredibly high relapse rates. More knowledge is needed about the specific brain circuits and cell types that express the mu opioid receptor through which opioids act. This proposal will investigate the properties of such cells and circuits, with the ultimate goal of building upon these findings to uncover new therapies to mitigate opioid abuse and relapse.